The Role of Limch1 Alternative Splicing in Skeletal Muscle Function

Project Summary
The goal of this project is to determine the functional consequences of developmentally regulated and conserved
LIM and calponin homology domain 1 (Limch1) alternative splicing in skeletal muscle. Postnatal muscle
development is a highly dynamic period associated with extensive transcriptome remodeling. A significant aspect
of this process is widespread changes in alternative splicing, required for adaptation of tissues to adult function.
The functional significance of many developmental and tissue specific alternative splicing transitions is unknown.
These splicing events have significant implications since reversion of adult mRNA isoforms to fetal isoforms is
observed in many skeletal muscle diseases. Limch1 is a putative actin-binding protein with LIM and calponin
homology domains and several protein isoforms of unknown significance, generated by alternative splicing. The
Limch1 gene expresses a ubiquitous protein isoform (uLimch1) in most tissues and a skeletal muscle specific
isoform that predominates in adult skeletal muscle (mLimch1). mLimch1 contains an additional internal and in
frame 454 amino acids encoded by six contiguous exons simultaneously included after birth. The developmental
regulation and tissue specificity of this splicing transition is conserved in mouse and human. However, the
significance of including these six exons of Limch1 in adult muscle is yet to be determined. To determine the
physiologically relevant functions of mLimch1 and uLimch1 isoforms, CRISPR-Cas9 was used to delete the
genomic segment containing the 6 alternatively spliced exons of Limch1 in vivo, thereby forcing the constitutive
expression of the predominantly fetal isoform, uLimch1 in adult skeletal muscle (HOM Limch1 6exKO).
Preliminary grip strength analysis showed that adult male and female mice from two independent homozygous
(HOM) Limch1 6exKO founder lines had significant muscle weakness in vivo while maximum force and rate of
relaxation is impacted ex vivo compared to wild-type (WT) age-matched controls. I will use the HOM Limch1
6exKO mice to determine the contribution of the muscle specific Limch1 isoform to skeletal muscle physiology
and function. In the first aim, I will conduct extensive analysis of the HOM Limch1 6exKO mice through grip
strength testing to determine extent of progression with aging, a thorough panel of ex vivo contractility assays to
identify the predominant mechanism affecting force generation and skeletal muscle calcium analysis to identify
the physiological defects resulting from removal of mLimch1, the Limch1 isoform normally present in adult
muscle. In the second aim, functional characteristics of Limch1 protein will be delineated through in vivo
localization studies and identification of interacting protein partners to determine the underlying mechanisms
leading to strength loss in HOM Limch1 6exKO mice. By investigating the functional, spatial, and protein binding
characteristics of mLimch1, the role of tissue specific regulation of Limch1 in skeletal muscle homeostasis will
be uncovered. The results obtained from these studies will contribute to our understanding of the significance of
RNA processing in skeletal muscle development and disease.

Public health relevance
Project Narrative Many skeletal muscle genes undergo alternative splicing with isoform specific roles involved in tissue development, maintenance, and disease. This proposal focusses on the Limch1 gene which generates a conserved and developmentally regulated isoform, mLimch1 by alternative splicing, that contributes to skeletal muscle function. The studies proposed in this fellowship will provide insight into the mechanisms by which mLimch1 maintains adult skeletal muscle homeostasis and will enhance our understanding of the tissue specific outcomes of alternative splicing.